Glymphatic impairment as a crucial factor in particulate matter exposure related development of Alzheimer's disease pathology

Environmental toxicants and, more specifically, exposure to ambient particulate matter (PM) air pollution
increases the risk of developing Alzheimer's Disease (AD) and AD-Related Dementias (ADRD). Yet, our current
understanding of the mechanisms by which PM exposure augments the progression of ADRD-related pathology
and cognitive impairment is very limited. We posit that airborne ultrafine particles (UFP, <100 nm diameter) are
causally related to the development or progression of AD/ADRD. The glymphatic pathway is emerging as a key
to maintaining brain health and its dysfunction is implicated in several neurological disorders. This glial-
dependent clearance pathway is dedicated to draining soluble waste proteins and its existence has been
documented in the brain of multiple species, including humans. The proposal is based on preliminary studies
showing that exposure to model UFP significantly suppresses glymphatic fluid transport and increases the β
amyloid load in a murine model of AD pathology. We hypothesize that airborne UFP are transported to the
brain upon inhalation exposure and cause both systemic and neuroinflammation, thus either indirectly
or directly impairing glymphatic fluid flow and accelerating AD/ADRD-like pathology and behavioral
deficits in a mouse model of AD. The proposed aims will test our hypothesis by addressing the following
questions: Aim 1: How does short (3 days) or repeated (3 months intermittent) exposure to UFP affect glymphatic
fluid transport and cognitive performance in young (3 months) and aged (15 months) wildtype mice? Aim 2: Can
glymphatic impairment resulting from UFP exposure change the progression of Aβ deposition in a murine
AD/ADRD model? Aim 3: Will UFP accumulate and interact with cells along the major glymphatic fluid transport
segments? We will here use high-resolution analytical scanning transmission electron microscopy to analyze
precisely where in the brain parenchyma the UFP accumulate and interact. Aim 4: We will explore the molecular
mechanisms of UFP exposure-related glymphatic impairment and pathological progression in a murine
AD/ADRD model via pharmacological inhibition of adrenergic signaling. Moreover, a detailed study of AQP4
vascular polarization response to air particulate matter exposure, sleep disruption and how do adrenergic
inhibition reverse these signatures of pathology, would also be explored? The innovative aspects of the proposal
build upon a unique multidisciplinary approach where expertise in particulate matter toxicology (Elder), basic
and applied chemistry with particular focus on the study of UFP in living systems (Graham), neurobiology of
diseases and regenerative mechanisms (Hussain), and fundamentals of waste products and metabolites
clearance (Nedergaard), will be combined to address the question if and how do UFP enter, distribute,
accumulate, and ultimately undergo bioprocessing and efflux from the brain.
The proposed experiments represent the first fundamental analysis and mechanistic underpinning of the
interconnection between PM exposure, glymphatics, inflammation, and ADRD initiation and progression.

Public health relevance
Project Narrative A decline in brain fluid transport has been suggested to play a critical role in Alzheimer’s disease-related dementias. The proposed studies are based on the observation that short time exposure to inhaled ultrafine particles suppressed brain fluid transport. The proposed studies will identify the mechanistic link between air pollution and the increased risk of dementia.